Characterizing the regulation of cell envelope biosynthesis in Pseudomonas aeruginosa

Project Summary/Abstract
The bacterial cell envelope is a multi-layered structure that performs a variety of critical functions such as
providing protection from physical and chemical insults, including antibiotics. The cell envelope is essential to
viability but how cell envelope biogenesis is regulated is poorly understood. Gram-negative bacteria are
characterized by a cell envelope with three layers: an inner membrane composed of glycerophospholipids
(GPLs), a cell wall made up of peptidoglycan (PG), and an asymmetric outer membrane in which the inner leaflet
is comprised of GPLs and the outer leaflet is enriched in lipopolysaccharide (LPS). The biosynthetic pathways
responsible for the production of LPS, PG, and GPLs rely on shared precursor pools. Specifically, LPS and GPLs
both require acyl-acyl carrier proteins and LPS and PG both require UDP-N-acetylglucosamine. Thus, although
it is important that enough LPS, PG, and GPLs are produced to support growth, it is critical that each biosynthetic
pathway is tightly controlled to prevent runaway flux that could deplete the shared precursor and indirectly inhibit
the production of another essential cell envelope component. Despite the importance of balanced cell envelope
biosynthesis, little is known about the regulatory systems that control cell envelope biogenesis outside of
classical model systems. Work in my laboratory is focused on identifying and characterizing the various
processes that regulate cell envelope biosynthesis in Gram-negative bacteria, with a particular focus on the
opportunistic pathogen Pseudomonas aeruginosa. I previously found that, in P. aeruginosa, the LPS and PG
biosynthetic pathways are coordinated through a regulatory interaction between their committed enzymes, LpxC
and MurA, respectively. Genetically uncoupling LPS and PG biogenesis resulted in measurable phenotypic
changes such as loss of viability and alterations to cellular morphology, highlighting the importance of maintaining
balanced cell envelope biosynthesis. Current studies in my laboratory have identified additional factors that
appear to influence the equilibrium between LPS and PG production, indicating that the regulation of these
pathways is multi-faceted. Over the next five years, my group will seek to further clarify the regulation of cell
envelope biogenesis in P. aeruginosa using a combination of genetics, biochemistry, cell biology. The goals of
this proposal are to (i) dissect the molecular basis of LPS and PG coordination along with the physiological
consequences of uncoupling the two pathways, (ii) characterize two novel regulators of cell envelope biogenesis,
and (iii) define the array of factors that control LPS, PG, and GPL production in P. aeruginosa. In addition to
laying the groundwork for future therapeutic development in an organism infamous for antibiotic resistance, this
work has the potential to provide insight into fundamental principles that govern bacterial physiology and cell
envelope biosynthesis.

Public health relevance
Project Narrative The bacterial cell envelope is a complex multi-layered structure that is built from multiple overlapping biosynthetic pathways which must work in concert to support cellular growth. This project is focused on understanding molecular details underpinning the regulation of cell envelope biosynthesis in the pathogenic bacterium Pseudomonas aeruginosa, which poses a serious health threat to individuals that are immunocompromised or those with cystic fibrosis. Our work not only has the potential to identify new targets for antibiotic development, but also uncover new concepts that are broadly applicable to diverse physiological processes.